Dissecting the Mechanism for Transient ER Stress-Induced Anti-Tumor T Cell Response

ABSTRACT
The development of T cell immunotherapies over the past decade revealed that the reinvigoration of anti-tumor
immunity could be achieved by manipulating mitochondrial dynamics in T cells. The endoplasmic reticulum (ER)
and the mitochondria coordinate to maintain cellular homeostasis, metabolism, and death. While persistent ER
stress responses cause mitochondrial collapse, moderate ER stress conditions promote mitochondrial function.
Strategies to boost anti-tumor T cell function by targeting ER-mitochondrial crosstalk have not been exploited
yet. We used carbon monoxide (CO), a short-lived gaseous molecule, to test if engaging in moderate ER stress
conditions can improve T cells' mitochondrial and anti-tumor functions. Using melanoma antigen-specific T cells,
we identified that CO-induced transient activation of the ER stress sensor ‘protein kinase R-like endoplasmic
reticulum kinase (PERK)' dramatically increases anti-tumor T cell function by engaging autophagy. Using a dual
reporter, the LC3-GFP-RFP mouse, we found that, in response to transient ER stress (imposed by CO), T cells
substantially increase the LC3-GFPpos population (that prepare themselves to undergo active autophagy)
compared to those that fail to enter the process (LC3-GFPneg). We noted that the LC3-GFPpos T cells inherited
healthier mitochondria and showed improved tumor control. Moreover, LC3-GFPpos and LC3-GFPneg T cells
showed distinct metabolic epigenetic profiles. Overall, our preliminary data highlights that transient ER stress-
activated autophagy pathways modify mitochondrial function and epigenetically reprogram T cells towards a
superior antitumor phenotype. Based on the existing literature and our preliminary data, CO-induced transient
PERK activation followed by autophagy influences a combination of events, including mitochondrial quality,
metabolic, and epigenetic programming, leading to the reinvigoration of exhausted anti-tumor T cells and
increased T cell effector function in the TME. Experiments are proposed to test this hypothesis with the following
aims: 1) To determine how CO-induced mitochondrial quality control mechanisms regulate T cell effector
function. 2) To determine how autophagy-induced altered metabolite ratios epigenetically reprogram anti-tumor
T cells. 3) To determine if CO induced autophagy improves the anti-tumor efficacy of human TILs and CAR-T
cells. We believe the successful completion of the proposal will: a) help us identify mitochondrial signaling
molecules that regulate T cell effector functions to improve tumor immunotherapy. b) will identify the
dysfunctional mitochondria-derived metabolites and the epigenetic programs that regulate the gene expression
profile associated with effector functions and longevity of the T cells in the TME. c) Finally, successful completion
of the proposed studies will provide a comprehensive mechanistic understanding and testing strategies (such as
using CO) with TILs and TCR/CAR-transduced T cells, which will lead to improved translational outcomes
required for treating solid tumors and drastically reduce the cost of ACT.

Public health relevance
NARRATIVE Cancer treatments that overcome the malfunctioning of T cells brought on by tumors, which frequently compromises long-term tumor control, is much needed. This application uses carbon monoxide (CO)-induced transient ER stress as an ex vivo immunomodulatory strategy to trigger mitochondrial reprogramming and attaining long-term tumor control upon adoptively transferring tumor reactive T cells. The experiments are intended to shed light on the molecular, metabolic, and epigenetic signature in regulating CO-mediated ER- mitochondria crosstalk and the function of protective autophagy in determining anti-tumor T cell fate and function that enables long-term control of established tumors in vivo.